Modeling mechanisms in cytokinesis, cell polarization and motility

Project Summary/Abstract
The ability of cells to divide, establish a polarization direction, and move by crawling requires the coordinated
interactions of the cytoskeleton with membranes as well as with the signaling system organizing on
membranes. A major challenge for the development of predictive mathematical and computational models of
these mechanisms of subcellular organization is accounting of how highly specific interactions at the molecular
level lead to the emergent collective behavior. We address this complexity by employing computational and
modeling methods linking molecular to cellular scales, in close collaboration with experimentalists. As our
models progress to incorporate more accurate descriptions of the underlying molecular mechanisms, they
require use of High-Performance Computing (HPC) resources. In particular, two of our projects are entirely
dependent on HPC. (1) Cytokinesis. We are modeling how the contractile ring forms through the condensation
a broad band of membrane-bound nodes containing myosin and formin. We apply coarse-grained biophysical
modeling to understand the ultrastructure of nodes and how this organization impacts their ability to capture
and pull actin filaments. (2) Cell and organelle motility. We develop filament-level actin network models that
account for their dendritic network structure, distributed turnover, force transmission and mechanical regulation
of branching and severing. This supplement request will allow us to purchase 8 computing nodes that will be
added to Lehigh University's HPC cluster Sol/Hawk. Each node will provide us with 450,000 core hours (SUs)
per year for a total of 3.6 million SUs per year.

Public health relevance
Project Narrative We will study the dynamics of the actin cytoskeleton within cells, which regulates their shape and motion, such as during organism development, differentiation, neuron function, or cancer cell metastasis. To address the complexity of cellular dynamics, the project combines mathematical modeling with experimental studies by collaborators. If successful, this basic science would underpin future medical research based on an understanding of cellular function.